ACHIEVE Investigator Development Core

Abstract
The overarching goal of the Investigator Development Core (IDC) is to create a climate where
collaborative and innovative research can thrive, leading to improved population health through sound
research and implementation science. The IDC will provide opportunities for a diverse cohort of highly
skilled early-stage investigators (ESI) to develop and pilot innovative research studies by efficiently
leveraging existing resources across three major research institutions in the proposed ACHIEVE
GREATER. The IDC will provide training and consultation on study design and biostatistics, provide a
seed funding program, and facilitate access to key infrastructure including banked biospecimens and
electronic health records, and an array of data located in the newly developed Wayne State
University (WSU) Google-Cloud-based data warehouse, ingestion, and dissemination platform. The
core function of the IDC is to promote the research careers of the pilot project awardees to become
highly competitive applicants for competitive extramural support. The IDC will specifically encourage
early-stage investigators from different disciplines and backgrounds to focus on chronic disease
disparities to enhance workforce diversity. The specific aims of the IDC are to plan each year's
funding opportunity with input from our community advisors and ACHIEVE GREATER program
leaders. This program will be available to the ACHIEVE GREATER membership and broader Wayne
State University (WSU), Henry Ford Health System (HFHS) and Case Western Reserve University
(CWRU)/University Hospitals (UH) research communities. Interested applicants will submit a letter of
intent (LOI) which will be reviewed by the Scientific Advisory Committee ( SAC). Applicants with
highly meritorious LOIs will be invited to submit a full application and will receive assistance from the
administrative core on biostatistics, study design, IRB and other regulatory matters. The IDC will
award six new pilot project grants each year of the 5-year ACHIEVE GREATER funding cycle with
each award including funds of $40,000 over a 1-year period. In addition, we will provide awardees
with programmatic support, which includes IRB as well as statistical support at no cost to them. The
IDC Director (Dr. Safwan Badr – WSU) and Assistant Director (Dr. Sadeer Al-Kindi – CWRU) will
oversee an advisory team that meets regularly with ACHIEVE GREATER pilot project recipients to
review progress and provide guidance. Finally, we will track success measures including publications
and competitive extramural awards. Overall, the IDC will nurture and support transformational
research on chronic disease prevention with favorable impact on population health.